Neural circuits for flexible audiomotor learning

The mammalian auditory system is remarkably adaptive; salient experiences and behavioral
contexts can fundamentally alter the processing of sounds in order to sensitize neural circuits to
behaviorally relevant information. How does the central auditory system learn to associate
sounds to rewards, and relatedly, how does behavioral context mediate this plasticity? The
formation of representations of sensory signals such as speech, music, and other forms of
acoustic learning is critical for survival. And, yet, the formation of these representations during
real-time learning remains largely unknown. In this proposal, we posit that learning can be
dissociated into two distinct learning processes: the initial acquisition and subsequent
expression of knowledge. Acquisition involves learning the core discrimination learning that
underlie a behavior, and expression entails the use of this acquired discrimination in context.
Acquisition and expression have typically been conflated in most laboratory tasks, leaving an
important gap in our understanding of learning mechanisms in the central auditory system.
Moreover, dissociating between acquisition and expression has important implications for
development and language disorders. For example, soothing music can elicit neurotypical
behavior in autism patients with otherwise severe symptoms. We aim to identify the separable
neural mechanisms that enable sensorimotor acquisition versus contextual expression.
Recently, we have shown that we can precisely dissociate acquisition from expression in a
sensorimotor reward learning task. Thus, we now have a powerful behavioral approach to
isolate acquisition from expression during learning. In this proposal, we will define the precise
neural circuitry in the auditory cortex that enables these two aspects of learning. The auditory
cortex is known to be a major site of plasticity; associative learning between sounds and
rewards induce shifts in the “tuning” of cortical neurons. The cholinergic basal forebrain,
moreover, has been implicated as a potent driver of receptive field plasticity in the central
auditory system. These plasticity mechanisms likely reflect fundamental neural changes that are
linked to acquisition of task knowledge. A1 is also heavily modulated by brain state and context,
suggesting that A1 may also play a role in expression of task knowledge. Here, we propose to
combine simultaneous real-time two-photon imaging of neurons in the auditory cortex (Aim 1)
and cholinergic axons (Aim 2-3). We will perform causal manipulations of AC (Aim 1),
cholinergic activity (Aims 2-3), in vivo whole-cell voltage clamp recordings (Aim 2), and detailed
behavioral analysis (Aims 1-3) to determine the neural basis of audiomotor learning.

Public health relevance
Project Narrative Our work hopes to identify general circuit rules and dynamics that enable neuroplasticity and we argue that behaviorally-relevant plasticity is not only about the acquisition of knowledge but also the ability to use that knowledge in the appropriate behavioral context. Diseases such as post-traumatic stress disorder (PTSD), language disorders, and autism may hijack these parallel learning mechanisms in distinct ways to drive pathology. This proposal provides essential data on basic auditory learning mechanisms that will enable a fundamental neurobiological basis to explore a myriad of neurological disorders.